Leveraging the genetics and biochemistry of UNC-13 to uncover mechanisms driving neurotransmitter secretion

PROJECT SUMMARY
Communication between cells in the brain occurs predominantly via chemical secretion in neuronal
specializations called presynaptic terminals where synaptic vesicles (SVs) fuse with the plasma membrane to
release neurotransmitter molecules. These membrane fusion events are tightly controlled and modulated by key
synaptic proteins such as the neuronal SNARE proteins as well as Munc13-1/UNC-13, Munc18-1/UNC-18,
Complexin, and Synaptotagmin. Munc13-1 is major hub for every step in synaptic transmission. Moreover,
mutations in the human UNC-13 ortholog are associated with severe neurological and developmental disorders.
Importantly, the mechanisms underlying the various Munc13-1 functions are largely unknown. We recently
characterized a novel domain at the C-terminus of Munc13-1 termed HC2M that plays a role in SV
docking/priming, and mutations in this domain have a devastating impact on synaptic transmission and nervous
system function in the model organism C. elegans. Using a combination of genetic, behavioral, imaging, and
biochemical methods, we will investigate the role of UNC-13 in driving the assembly of the neuronal SNAREs, a
critical first step in SV priming. This project will shed light on some of the enduring mechanistic mysteries
underlying synaptic transmission.

Public health relevance
PROJECT NARRATIVE UNC-13 is a large synaptic protein that is important for several synaptic fusion processes, including synaptic vesicle (SV) docking and priming, lipid-binding, and SNARE complex assembly/disassembly regulation. Mutations in the HC2M and MUN domains of UNC-13 are associated with developmental disorders, seizures, and musculoskeletal abnormalities. Our research plan uses a combination of genetic, behavioral, and biochemical methods to investigates the mechanism of UNC-13 in synaptic transmission with a particular focus on the MUN and HC2M domains.